Topographic, cell type and molecular pathway characterization ofAlzheimer's disease using single cell transcriptomics and epigenomics

ABSTRACT (PROJECT 2)
Alzheimer's disease (AD) is a highly penetrant neurodegenerative disease projected to affect 13.8 million
cases in the US by 2050 at a cost of $1.1 trillion if no treatment is developed. AD is characterized by stereotyped
progressive neurodegeneration and accumulation of two misfolded proteins in brain regions important for
cognition and memory. Neurofibrillary tangles (NFTs) of hyperphosphorylated tau follow a progression like
neurodegeneration, while extracellular amyloid beta (Aβ) plaques are initially detected in cortical and deep brain
structures. It is unclear whether these pathologies are causal or effects of other underlying processes and
currently no anti-tau or anti- Aβ therapies stop or reverse AD. Gene expression studies of AD have largely been
performed on tissue or cell populations, and impact of neuronal loss and gliosis on these results is unknown.
Epigenetic modifications are also associated with AD, though methylation studies have produced conflicting
results and no clear pattern of epigenetic dysregulation associated directly with AD progression has emerged.
The present study adapts recently developed high-throughput, single-cell methods for transcriptomic and
epigenetic analysis to the identify molecular and gene regulatory hallmarks of “clinically typical” AD without
significant co-morbidities. Building off a detailed understanding of neurotypical adult cell types, the project aims
to identify transcriptional changes in specific cell types or classes correlated with increasing severity of AD
pathology in different brain regions affected by the disease, and then identify gene and chromatin accessibility
changes with pathology in vulnerable cell populations. This project will initially optimize single nucleus RNA-seq
and epigenetics methods for use with postmortem samples of varying pathology and tissue quality, and generate
reference datasets for brain regions to be analyzed in AD. Low-cost, droplet-based single nucleus RNA-seq will
then be used to classify and characterize cell types in regions differentially affected by tau and amyloid pathology
from many donors spanning AD progression with quantified tau and Aβ pathologies. A broader set of brain
regions will then be surveyed on a subset of cases with consistent AD-related phenotypes to understand whether
there is a common AD signature across brain regions, and whether signatures of AD can be detected prior to
the emergence of neuropathology. Finally, higher-resolution methods will target transcriptomic and epigenetic
changes in AD associated with pathology and disease diagnosis in specific cell types, aimed at achieving a
mechanistic understanding of AD phenotypes. Using this design, this project can directly probe dysregulated
gene networks within affected cell types for the first time, providing a potential causal link between genetic or
epigenetic states and resulting gene expression. The resulting datasets and platform will produce valuable
insights into the cellular and molecular basis of AD and will be made publicly accessible through the Data Core.

Public health relevance
PROJECT NARRATIVE (PROJECT 2) Alzheimer’s disease follows a highly stereotyped progression that differentially affects cell populations in the brain, and yet transcriptomic and epigenetic studies to date have largely focused on bulk tissue comprised of mixed cell populations, potentially obscuring key cell type-specific differences. The project proposed here will apply cutting edge single cell transcriptomic and epigenomic analysis in brain regions affected by Alzheimer’s disease (AD) pathology and across different stages of the disease to gain a dramatically higher resolution understanding of the cellular specificity of AD pathology and to identify signatures of the early pathogenesis of AD prior to the emergence of pathology. These data will help to understand differential vulnerability or resistance of specific cell types in AD, and push towards a mechanistic understanding of AD progression by identifying dysregulated gene networks within affected cell types.